Coding and Noncoding RNA Contributions to 22q11.2 Deletion Syndrome

Project Summary/Abstract
22q11.2 deletion syndrome (22q11.2del) is the most com~mon human microdeletion syndrome known,
affecting some 1/4000 individuals. Most patients have a 3 Mb deletion on one copy of chromosome
22q11.2, resulting in a haploinsufficiency of over 107 genes, 46 protein coding and the remainder
noncoding RNAs and pseudogenes. Children born with this deletion can have a range of congenital
anomalies that often include three that are developmentally linked; hypoplasia of the thymus,
congenital heart defects (CHD), and hypoparathyroidism. Approximately 60-70% of the patients have
an immunodeficiency due to reduced T cell output from a hypoplastic thymus and are often clinically
referred to as having DiGeorge syndrome. The underlying mechanisms causing the defective
formation/patterning of the thymic tissue remains poorly understood. Our results, obtained during the
previous cycle of this grant, suggest a defect among the neural crest derived mesenchymal cells,
which form the thymic capsule and vasculature and regulate the expansion of the thymus. In our first
aim, the developmental abnormalities of the pharyngeal apparatus leading to the formation of a
hypoplastic thymus will be determined. Specifically, the role of the neural crest-derived mesenchymal
cells in regulating the development and expansion of the thymus will be studied. Embryonic thymii
from mouse models of 22q11.2del will be used in reaggregate fetal thymic organ cultures to define the
role of mesenchymal cells in the process of thymus expansion. RNA sequencing approaches,
including single cell RNA sequencing will be used to determine what mesenchymal transcripts are
involved in this process. These experiments will be complemented with a characterization of human
thymii from 22q11.2del patients and normal controls. In humans with 22q11.2del along with the
mouse models, there is a post-natal miRNA dysregulation noted. In aim 2, we will explore the
consequence of these miRNA changes using a combination of longitudinal studies in humans and
diverse mouse models. This will reveal whether the dysregulation of miRNAs impacts immune
functions pertaining to the thymus. Results from the two aims will enable us to develop better
strategies for restoring thymus functions in various clinical settings resulting in the hypoplasia of this
tissue.

Public health relevance
Project Narrative 22q11.2 deletion syndrome is the most common chromosomal deletion problem reported in humans, leading to multiple clinical problems that affect the immune, heart, and nervous systems. Our recent work is revealing important roles for coding and noncoding RNAs in affecting the severity of the disease. We will use patient studies and mouse models of 22q11.2 deletion syndrome to determine the impact of these RNA species in the formation and function of the thymus.